Optimal Management of HIV Infected Adults at Risk for Kidney Disease in Nigeria

PROJECT SUMMARY: Persons of African descent have a disproportionate risk for several forms of kidney
disease including diabetic nephropathy, arterionephrosclerosis (hypertension-attributed kidney disease), focal
segmental glomerulosclerosis (FSGS) and HIV-associated nephropathy (HIVAN), a distinct form of FSGS.
Kopp and Winkler et al have shown that variants in the apolipoprotein-1 (APOL1) gene confer sizeable odds
ratios (OR) for FSGS (OR = 17), HIVAN (OR = 29 in the US; 89 in South Africa), and hypertension-attributed
kidney disease (OR = 7). These variants are present only on African-origin chromosomes and represent an
evolutionary protective mechanism against African trypanosomiasis. The presence of these risk genotypes is
highest in West Africa, and specifically in Nigeria among persons of Hausa, Fulani, Igbo, and Asante descent.
Markers of kidney disease include microalbuminuria, proteinuria, and/or reduced estimated glomerular filtration
rate (eGFR). All three have been associated with increased mortality in HIV-infected adults. Increased urinary
albumin excretion has diagnostic and prognostic value in the initial identification and confirmation of renal
disease, and changes in albuminuria can be useful in assessing the effectiveness of therapy as well as the
progression of the disease. The renin-angiotensin aldosterone system (RAAS) is recognized as the central
player in the pathophysiology of CKD based on numerous clinical trials in diabetics. The blockade of RAAS
with angiotensin converting enzyme inhibitors (ACE-I) is a well-recognized strategy to slow down renal disease
progression in diabetic patients with CKD. Aldosterone, together with angiotensin II, has been shown to
mediate oxidative stress, inflammation and tissue fibrosis. Therefore by more aggressively blocking RAAS via
the addition of an aldosterone receptor antagonist to an ACE-I, one may be able to elicit a more potent and
durable response thereby altering their risk trajectory for the development of potentially serious kidney
complications. To evaluate this at-risk population more in-depth and to determine the optimal means to reduce
their risk for renal complications, we plan to screen 2,200 HIV-infected adults receiving suppressive ART (≥ 6
months) at the Aminu Kano Teaching Hospital; to conduct the following Specific Aims:
1) To determine the prevalence of APOL1 variants and assess whether their presence correlates with
prevalent albuminuria, median eGFR, and/or CKD.
2) To assess whether RAAS inhibition (with the ACE-I lisinopril) compared to placebo will significantly
reduce the risk of kidney complications; and
3) To evaluate whether more aggressively blocking the RAAS system via the addition of the
mineralocorticoid antagonist spironolactone (in addition to lisinopril) is an even more potent means of
sustainably reducing the risk of kidney complications in this population.

Public health relevance
PROJECT NARRATIVE In this study, we plan to determine the optimal means to manage and thereby reduce the risk of kidney and potentially other end organ complications among genetically at-risk northern Nigerian HIV-infected adults. Based on data from the diabetic literature using medications that block the renin angiotensin aldosterone system (RAAS), we plan to evaluate whether or not RAAS inhibition (using one or two different medications that block RAAS) in HIV-infected adults produces similarly promising results.